Angiotensins, Prostaglandins and Adrenergic Interactions

This proposal is aimed to test our novel hypothesis that the cytochrome P450 (CYP)1B1-generated
metabolites of 17b-estradiol (E2) (2-methoxyestradiol, 2-ME) and testosterone (T) (6b-hydroxytestosterone,
6b-OHT) inhibit and enhance, respectively, Ang II-induced production of prohypertensive arachidonic acid
(AA)-12/15 lipoxygenase (ALOX15)/12(S)-hydroxyeicosatetraenoic acid (HETE) and Cyp4a/20-HETE
metabolites in the paraventricular nucleus (PVN) and that this mechanism accounts for the sex differences in
Ang II-induced hypertension, i.e., a lesser increase in blood pressure (BP) in females than males. This
hypothesis is based on our compelling preliminary data that transduction of PVN with adenovirus (Ad)-
ALOX15, and Ad-Cyp4a10/Cyp4a12a-shRNA, respectively, a) ameliorate Ang II-induced increase in BP in
both wild-type (WT) female and male mice; b) attenuate the effect of Ang II to enhance BP, in CYP1B1 gene
disrupted (Cyp1b1–/–) female mice that lack 2-ME; and c) minimize the 6b-OHT effect to restore Ang II-induced
increase in BP that is diminished in Cyp1b1–/– male mice lacking endogenous 6b-OHT. We will expand these
observations to test our hypothesis by addressing the following specific aims. Aim 1. To determine contribution
of the central AA/LOX15 system to Ang II-induced hypertension and its pathogenesis in female and male mice.
Sub-Aim 1. To examine interaction of the central AA/LOX15 system and CYP1B1-generated E2 and T
metabolites in Ang II-induced hypertension and its pathogenesis in female and male mice. Aim 2. To examine
contribution of the central AA/Cyp4a10 and Cyp4a12a systems to Ang II-induced hypertension and its
pathogenesis in female and male mice. Sub-Aim 2. To determine interaction of the central AA/Cyp4a10 and
Cyp4a12a systems and CYP1B1-generated E2 and T metabolites in Ang II-induced hypertension and its
pathogenesis in females and male mice. To achieve these aims, we will use the state-of-the-art techniques,
which include: a) Radiotelemetry for measuring BP; b) wild-type and Alox15–/–, Cyp1b1–/–, and cPLA2a–/–
female and male mice; c) Ad-ALOX15-shRNA, Ad-Cyp4a10, and Ad-Cyp4a12a-shRNA and respective Ad-
scrambled shRNA controls, and their Ad-DNA and Ad-GFP-DNA control, and 12(S)-HETE Gpr31 and Ltb4r2
and 20-HETE Gpr75 receptor siRNAs and their non-target siRNA; d) Histological, immunohistochemical, and
fluorescence microscopy and biochemical techniques; e) Flow cytometry to determine immune cell infiltration
in aorta, kidney and brain; f) UPLC/qTOF MS for the analysis of sex steroids and eicosanoids. The proposed
studies will provide insights into the molecular mechanism underlying sex differences determined by the
interaction of CYP1B1-generated metabolites of sex steroids and AA/ALOX15- and Cyp4a systems in the PVN
in Ang II-induced hypertension and associated pathogenesis. Moreover, these studies should identify central
ALOX15 and Cyp4a as a potential site of action of the selective inhibitors of these enzyme systems and 12(S)-
HETE and 20-HETE receptor antagonists for treating hypertension and its pathogenesis in both sexes.

Public health relevance
The proposed studies will advance our understanding of the molecular mechanisms underlying sex differences as determined by the interaction of cytochrome P450 (CYP)1B1-generated metabolites of estrogen and testosterone and arachidonate-12/15lipoxygenase, and CYP4a generated prohypertensive metabolites in the brain in an experimental model of angiotensin II-induced hypertension and associated pathogenesis. Furthermore, these studies would identify these enzyme systems in the brain as a potential site of action of selective inhibitors for treating hypertension and associated neuroinflammation, vascular dysfunction, and kidney damage in both sexes.